A Comprehensive Resource for Manipulating the Drosophila Genome

PROJECT SUMMARY
We propose to generate GFP protein trap alleles for 295 fly orthologs of human genes associated with AD
based Genome Wide Association Studies (GWAS), AD genome sequencing efforts, and other bioinformatics
tools. The parent grant for this supplement R24 GDP OD031447, supports the Drosophila Gene Disruption
Project (GDP) that generates GAL4 gene trap alleles for genes that are orthologous to human genes. These
GAL4 gene trap alleles create severe loss of function alleles of the targeted gene to allow phenotypic
characterizations. They also allow to determine the expression pattern of the gene and can also be used in
combination with UAS-cDNA transgenes to rescue the phenotypes induced by the GAL4 insertion. This allows
us to assess rescue with the reference cDNA of the human orthologue as well as the variants found in patients.
The GFP protein trap alleles that we propose to generate here are highly complementary to the GAL4 gene
trap alleles and enable very different experimental strategies. The GFP protein trap alleles allow us to
determine subcellular localization of the targeted gene product. Additionally, the GFP tagged protein can be
used to immunopurify the protein together with its binding partners, allowing the identification of interacting
proteins through Mass spectroscopy. In addition, we developed a strategy to remove the GFP protein in a
temporal and tissue specific fashion that is reversible in any tissue or cell type based on the DeGradFp method
and temperature shifts. Hence, creating a GFP protein trap allele to accompany every GAL4 gene trap allele
very significantly increases the breadth of information we can obtain for each targeted gene. With this
supplement, we will target a subset of the genes that we are generating GAL4 gene trap alleles, specifically
295 genes that have been proposed to be associated with AD with emphasis on the genes that are currently
understudied. We will use CRISPR mediated homologous recombination to integrate GFP protein trap artificial
exon in introns of genes that contain a suitable intron. For the genes where no such suitable intron can be
found, we will replace either the entire coding sequence or exons where we want to integrate GFP tag
depending on the size of the gene. We will employ the scarless DsRed dominant marker as a transgenic
marker that can be removed from the final tagged alleles. We will inject the above constructs and verify the
insertion site by genomic PCRs. Every generated fly line will be deposited to Bloomington Drosophila Stock
Center (BDSC) and all the associated information will be readily available in our public web site and Flybase.
We will select 20 GFP protein trap alleles for high priority genes where AD links are better established based
on previous studies and determine the subcellular localization of these proteins by immunostaining. We then
specifically remove the protein in adult animals using conditional GFP tagged protein removal using DegradFP
and iGFPi followed by behavioral studies, including longevity, climbing assays, and histological studies of the
brain to assess which genes will be pursued in further studies.

Public health relevance
PROJECT NARRATIVE We propose to tag 295 Drosophila genes that are orthologous to human AD risk factor genes, with GFP to allow probing experiments that characterize their function in vivo. These reagents will inform us about which cells in the body express the proteins, their subcellular protein distribution, the other proteins and molecules they interact with and the functional consequences of removal of the proteins in any tissues and at any time during their lifespan. These reagents will promote experiments to direct the AD field towards better understanding of the molecular and cellular pathogenic events as well as therapeutic strategies.